Task B04: Evaluation of an Antibody Therapeutic in the Cynomolgus Macaque Model of VEEV

This contract provides for the development and standardization of non-human primate models of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.